AUTONOMY, COLLABORATION AND JOB SATISFACTION AMONG GCRC NURSES

Masters thesis for GCRC nurse manager involving questionnaire to GCRC nurses regarding the relationship between autonomy, collaboration and job satisfaction among nurses who work in GCRCs.